A multidisciplinary BCC for ovarian cancer early detection: translating discoveries to clinical use with a by-design approach

Project Summary (Overall)
High-grade serous ovarian carcinoma (HGSOC) is the most common histological subtype of epithelial ovarian
cancer. The overarching goal of the proposed Biomarker Characterization Center (BCC) is to apply a by-
design approach based on biology of HGSOC pathogenesis and unmet clinical needs to identify, verify and
prioritize, and validate biomarkers, and to develop them into an in vitro diagnostic multivariate index assay
(IVDMIA) with the intended use to capture HGSOC in high-risk women at the early stages including i)
precursors, ii) confinement to the ovary/fallopian tube or iii) low-volume diseases in high-risk women (BRCA1/2
carriers). The biomarkers that we propose to discover and validate in this proposal are intended for early
detection but not necessarily for screening in general population. The BCC’s capability in advanced data
generation technologies, multiplexed target assay development, and bioinformatics/data science will serve as
resources for the EDRN. Based on the success of our current EDRN projects, this BCC will continue our on-
going biomarker development studies including the validation of candidate biomarkers that we have identified
through the current BDL. We propose the following specific aims:
1. To optimize and use novel specimen collection and processing technologies, and an iterative and
cumulative process that takes advantage of our newly gained knowledge of the biology in ovarian cancer
pathogenesis. BDL
2. To optimize and apply innovative bioinformatics, data sciences, and AI/ML tools that incorporate existing
knowledge and data to improve discovery of low frequency biomarkers that with their functionally shared
pathways/networks could collectively deliver an improved sensitivity while retaining a high specificity. BDL
3. To further develop and optimize the process for efficient multiplex targeted assay development with respect
to analytical performance, throughput, and specimen volume requirement for a broad spectrum of
candidate biomarkers using a “fit for purpose” approach. BRL
4. To optimize and apply a by-design approach to translating discoveries into clinical tests. Its application had
been critical in the development of two FDA cleared tests by JHU team members for the preoperative
assessment of ovarian malignancy risk. BDL/BRL
5. To provide expertise and analytical and data science capabilities to the entire EDRN community.
The multi-disciplinary team that we have assembled (molecular cancer biology, pathology, clinical chemistry,
mass spectrometry, biostatistics, data science, bioengineering), the unique, novel yet biologically and
statistically sound approaches, and our long-standing experience in biomarker research and translating
discoveries to FDA cleared clinical tests all together ensure the success of this proposed BCC.

Public health relevance
Project Narrative This application aims to establish a biomarker characterization center to identify biomarkers in clinically easily accessible samples and to develop them into clinical tests to capture high-grade serous ovarian carcinoma (the most common and deadliest form of ovarian cancer) at the early stages when surgical and therapeutic treatment may still be able to change a patient’s long-term survival. The initial development and testing will be in high-risk women population.